DIVERSE ROLES OF COPPER AND ZINC IN BIOLOGICAL SYSTEMS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We will be extending our previous work on the copper enzyme particulate methane monooxygenase (pMMO), the zinc enzyme dihydroorotase (DHOase), and copper-selenium and copper-sulfur complexes with potential antioxidant properties.